Molecular Determinants of the Alveolar Epithelial Plasticity Window

PROJECT SUMMARY
The alveolus is lined by two epithelial cell types: thin gas-exchanging alveolar type 1 (AT1) cells and cuboidal
surfactant-producing AT2 cells. Both are selected from a common distal progenitor by FGF, Notch, and stretch
signaling. Injury in the adult lung activates AT2 into a facultative progenitor state to regenerate lost AT1 and AT2
cells. While the inductive cues that select fate have been identified, it is less clear what role – if any – repressive
cues play in fate maturation. Two gaps of understanding in the lung field are 1) when and how is stemness lost
after fate selection and 2) once lost, how is stemness re-accessed by AT2s after injury to regenerate the alveolar
epithelium. Our recent work indicates perinatal AT2s retain stemness for weeks after fate selection, despite being
transcriptionally and functionally differentiated. This proposal focuses on a putative repressor of AT2 stemness,
determining its target and modes of action, whether and how it is overridden in adult AT2s to re-access stemness,
and investigating the extent to which it is dysfunctional in pulmonary fibrosis - wherein aberrant AT2 states are
observed. Our first aim focuses on a putative repressor of stemness we identified, the CCAAT enhancer binding
protein C/EBPα. Using transgenic mouse models, we will test the requirement of Cebpa for AT2 stemness and
determine whether the targeted stemness program acts in a cell autonomous or non-autonomous manner by
mosaic deletion. Next, scRNAseq, ATAC- and ChIP-seq will identify genes targeted by, as well as molecules
interacting with, C/EBPα. Finally, we will use organotypic culture and transgenic mouse experiments to determine
whether timing of Cebpa expression is itself regulated earlier in development by the polycomb repressive
complex PRC2. The second aim of the proposal is to determine whether and how C/EBPα regulation is
overridden following injury to re-access AT2 stemness and promote repair. We will determine whether C/EBPα
downregulation and AT2 stemness is dependent on AT1 cell death in vivo by performing genetically targeted cell
type specific ablation. Finally, we will compare the spatiotemporal program of C/EBPα regulation we identify
during injury and repair to the fibrotic lung and investigate whether it is dysfunctional in its associated aberrant
AT2 cells. Our approach is innovative, as no transgenic mouse experiments using mosaic deletion or lineage
tracing have been performed for Cebpa in the lung, nor have precise cell ablation studies been conducted in the
adult lung to study C/EBPα regulation. Further, the observation of retained stemness in perinatal AT2 cells is
novel and thus no investigation has implemented a multi-omics approach to understand its underlying
mechanism. Finally, little is known on the role repressive cues play in AT2 cells differentiation and maturation. If
successful, we will have uncovered a novel mechanism of AT2 stemness regulation for the lung field which will
be informative in understanding pulmonary diseases with aberrant epithelial differentiation. Further, our findings
will guide development of novel diagnostics or therapeutics, either for direct use in patients or in culture to control
stem cell differentiation through reprogramming patient’s adult AT2 cells.

Public health relevance
PROJECT NARRATIVE During embryonic development of the pulmonary alveolus, a common progenitor gives rise to two distinct epithelial cell types that must be differentiated prior to birth for newborns to breathe. Recent work suggests that one of those cell types retain stemness for a period after birth, suggesting a novel mode of molecular regulation. We propose a hypothesis ––and our data strongly support–– that a developmentally timed repressor of stemness is activated to reinforce cell fate that, during adulthood, is dynamically toggled after injury to re-access stemness and promote repair; if true, this hypothesis will update the model of differentiation of the alveolar epithelium and have fundamental implications for understanding lung disease and regeneration, which we begin to investigate in this proposal.